Core C: Data

Abstract – Data Core
The primary purpose of the Data core is to collect, store, coordinate, and transfer all data, metadata, and
analysis strategies generated within the U19 center (the INTERCEPT pain center) to the U24 DCIC and the
HEAL Platform. The Data core will conduct multiple inter-disciplinary genomic and statistical analyses to study
and integrate the multi-level omics data obtained from the three individual component projects of the
INTERCEPT Center. The INTERCEPT Center projects involve extensive data management and complex
analyses. Such analyses require organized and simultaneous consideration of data from different component
projects, and demand robust and innovative integrated analysis methodology. The Data core provides the
required data management and coordination function, as well as the bioinformatic expertise and innovative
integrated genomic analysis to enable the success of the INTERCEPT Center. The main objective of the Data
core is to serve as a backbone support resource for experimental design refinement, data quality control,
management, integration, analyses, and interpretation, and serve as a central hub to foster data and
information exchange and collaboration between individual projects and cores in the INTERCEPT Center. Built
upon the Core members’ close and long-time collaboration and extensive experience in multi-omics data
analyses, this Data core will provide essential services through the following specific aims: 1) Provide central
data storage, management, and information security services to all researchers within the U19 Center and
ensure the timely submission of data and data analyses to the HEAL Platform. 2) Integrated multi-omic
characterization of the peripheral nervous system to identify spatially resolved cells, genes, and pathways
associated with pain conditions.